RED CELL SODIUM TRANSPORT AND ION TRANSPORT WITHIN VARYING CONDITIONS

Samples from various clinical studies are evaluated for red cell Na transport and ion transport. Data is stored and analyzed at the CDMAS.